Research Translation Core

PROJECT SUMMARY The RTC works with all isrp faculty, staff and trainees to find ways to integrate strategic communication of their science into their activities. The major activities of this Core are designed to optimize opportunities for translating the findings of isrp research projects into meaningful outcomes that will benefit the public at large. These outcomes will be translated through an extensive portfolio of activities to connect to a wide and diverse set of stakeholders, including international and domestic scientists, Superfund Research Programs across the country, local, state, and federal policy-makers and the general public. We employ continuous evaluation to improve each core and investigator-initiated translational activity, to enhance the integration of RTC activities, and to ensure that the RTC maximizes the potential for the isrp to improve health and environmental health policy. The aims of the RTC are to: 1. Communicate within SRP to academic and research colleagues internationally, nationally and locally 2. Partner with government agencies to facilitate the development of sound public policies and practices 3. Formally transfer technology to commercial enterprises able to develop and deliver products or services to the public 4. Contribute to a broader public understanding of problems and solutions regarding environmental hazards and their remediation through information dissemination to other end users The Research Translation Core functions to convey the implications of isrp research to many audiences in a manner most appropriate to each. Specific innovations that distinguish our work are the organization of biennial international PCB workshops, outreach to and engagement of elected state legislators and their staffs, and the establishment and success of our rural science cafes, which bring isrp investigators and trainees to small, rural Iowa towns to engage lay audiences in learning about SRP work and how it affects their communities. These innovations are supported by a comprehensive, entrepreneurial approach to communicating results and activities to many audiences by many methods, including traditional media relations, social media, interactive web applications and decision support tools, and continuing education webinars in partnership with professional associations.

Public health relevance
PROJECT NARRATIVE The Iowa Superfund Research Program (isrp) addresses sources, exposures and toxicity issues related to airborne polychlorinated biphenyls (PCBs) through determination of sources and magnitudes of exposure, studies on mechanisms of toxic responses, and community-based participatory research that addresses body burdens of parent and metabolic products of atmospheric PCBs in adults and school children. Studies test the feasibility of using plants to degrade PCBs and remediate contaminated areas in an actual PCB-regulated site. The Research Translation Core facilitates the transmission of results of these and all laboratory and field studies to all stakeholders. In these efforts the Research Translation Core engages many audiences (academic, entrepreneurial, policy-makers and the general public).